TR&D3

D Cai and K Najarian will serve as Project Lead and co-Lead, respectively, for TRD3. Live fluorescence
imaging is challenged by high levels of autofluorescence background and potential for photobleaching and
phototoxicity. Faster frame rates are needed to capture subtle cellular behaviors, but an increase in imaging
speed may result in a reduction of signal. TRD3 will develop properly trained machine-leaning models that can
effectively denoise images captured with at least 5 times higher frame rates. Importantly, a faster frame rate
can significantly mitigate motion artifacts, which is critical to interpret images collected in vivo and track
biological processes. Environmental perturbations and movement can blur individual images, and substantially
degrade the usefulness of video streams. Microendoscopy is especially sensitive to motion because the image
field-of-view is typically only a few hundred microns in dimensions. Image segmentation remains one of the
most challenging tasks in biomedical image processing, in particular, at the cellular level. Live imaging
normally results in uneven intensity distributions, noise patterns, weak edges, and frequently incomplete
features. Rapid advances in the deep learning field has dramatically improved the accuracy of feature
extraction from in vivo fluorescence images using complex illumination and noise conditions, and have
increased in popularity with the development of massive parallel computing architectures. These algorithms
can enable precise image recognition based on high-dimensional hierarchical image features. Deep learning
algorithms can be trained using validated clinical datasets to provide real time digital readouts. In vivo cellular
activity visualized using microendoscopy will be correlated with their molecular properties via postmortem
tissue imaging. This approach allows for the dynamic behaviors of live cells visualized in vivo, and compared
with mRNA and protein expression to identify upregulated signaling pathways. Valuable insights into cellular
function and behaviors can be used to elucidate physiological mechanisms. Morphological profiles that are
versatile descriptors of biological systems can be generated and used to predict in vitro and in vivo drug
effects. New drugs can be developed, and their potential impact can be better understood. CP/SPs are
currently performing live imaging and molecular profiling separately using different sets of animals. Scientific
conclusions are drawn from statistical averages calculated from different cohorts. The number of experimental
animals needed to draw significant conclusions can be substantially reduced, and uncertainties introduced by
individual differences in statistical analysis can be minimized. TRD3 will support CP/SPs to advance their
scientific discoveries with higher accuracy and confidence. Synergy: TRD3 will use in vivo optical sections
collected by TRD2 to develop machine learning models for automated digital pathology, and will quantify tumor
dimensions to assess therapeutic efficacy using photoacoustic images collected with microsystems sensors
developed in TRD1.